Administration Core

Administration Core - Summary
The Transdisciplinary Center for Population Health (TCPH) Administration Core provides the overall leadership
and oversight of this COBRE. The Administration Core works to facilitate regional and national relationships to
help support the influx of trainees and recruitment of new investigators, thus creating a pipeline to bring high
caliber population health researchers to South Dakota that are vested in issues specific to American Indian (AI)
and rural health. The Administration Core will be responsible for all activities that support the COBRE,
including establishing effective communication mechanisms between Project Leaders, Mentors, and Core
Directors. Sound evaluation qualitative and quantitative metrics are used to perform a systematic evaluation of
to determine TCPH effectiveness and Project Leader progress. The COBRE Principal Investigator will perform
these functions in consultation with the Project Leaders, a Local Steering Committee, and an External Advisory
Committee.

Public health relevance
Administration Core - Narrative The Transdisciplinary Center for Population Health (TCPH) Administration Core has been designed not only to conduct the necessary operations of the COBRE grant, but to also use this opportunity to build regional capacity for population health research. The TCPH Administration Core is responsible for monitoring Project Leader mentorship plans, recruitment of additional investigators, providing communication mechanisms, and evaluating the success of the TCPH COBRE.